Metabolic Actions of Glucagon

Summary of Work
Glucagon is canonically viewed as an essential counterregulatory hormone that prevents hypoglycemia by driving
endogenous glucose production (EGP) in the liver. We and others have revealed additional roles for glucagon
that emphasize a much more complex control of metabolism beyond hypoglycemia. For instance, glucagon is a
potent insulinotropic peptide in β-cells, which we have shown to be essential for postprandial glucose control.
Furthermore, hepatic glucagon receptor signaling drives an increase in insulin sensitivity, which is a paradoxical
action for a counterregulatory hormone posited to limit insulin-induced hypoglycemia. However, insulin-
induced hypoglycemia is only a century old phenomenon that is unlikely to have had significant evolutionary
pressure. Collectively, it seems reasonable that the current dogma describing the metabolic actions of glucagon
exclusively in the hypoglycemic state is limited and incomplete. To this end, we have found that enhancing
endogenous glucagon secretion or providing exogenous glucagon to mice has limited efficacy at correcting
insulin-induced hypoglycemia. We have also found that glucagon receptor signaling in hepatocytes can engage
multiple signaling nodes. Based on these ideas, the primary hypothesis driving this work is that hepatic glucagon
receptors engage div ergent signaling pathway s that differentially regulate glucose metabolism. In addition to the
canonical pathways that increase EGP through G-protein signaling, glucagon can also utilize β-arrestin signaling
nodes to driv e insulin sensitiv ity. We propose to test our hy pothesis by carrying out complementary physiological
and pharmacological approaches in novel mouse models to resolve the role of hepatic glucagon signaling.
Importantly, we also propose to perform parallel experiments in human subjects to validate the translational
potential of this work. Unravelling this biology has significant implications on current and futureglucagon-based
therapies for both type 1 and type 2 diabetes, obesity, and liver disease.

Public health relevance
Project Narrative Our group, along with other researchers, have begun to reveal a much more complex role for glucagon beyond the prevention of hypoglycemia, raising questions about when and how glucagon may influence blood glucose levels. This proposal looks to detail how glucagon works to regulate glucose metabolism, based on new findings that suggest that glucagon signaling the in liver has more than one role, and that these multiple roles can be opposing in nature. Understanding this biology provides an opportunity to develop new generations of glucagon-based drugs that target specific pathways, making them more effective at controlling blood glucose.